Delineating ARF negative regulation of PAF1C-dependent oncogenic programs

PROJECT SUMMARY
Tumor suppressors (TS) tune the balance of cell growth and death by acting at multiple levels. Deregulation
of any of these hierarchies can promote tumorigenesis, impact cancer patient’s survival and response to currently
available treatments. Therefore, having a better understanding of these processes and the identification of novel
therapeutic targets upon TS loss is a priority in the field of cancer biology. Decades of work have defined how
the p14ARF (Alternative Reading Frame) TS operates in a p53-dependent manner to prevent tumorigenesis.
However, ARF also operates in a p53-independent manner to potentially “back-up p53”, but the mechanisms
remain poorly understood. There is a regained idea in the field to delve into tumor suppressive mechanisms and
to leverage the basic biology to therapeutic opportunities. In this context, the major goal of this research proposal
is to define how ARF (reactivated upon p53 loss) functions to restrain tumor promoter programs. Our unpublished
studies have defined a previously overlooked mechanism of ARF tumor suppression. First, upon p53 loss,
reactivated ARF selectively targets the Polymerase Associated Factor 1 complex (PAF1C) at genes encoding
the pro-growth GDF and BMP ligands to restrain abnormal cell growth. Second, loss of ARF in primary p53-/-
cells de-repress GDF/BMP programs leading to SMAD1/5 phosphorylation and target gene activation
(“oncogenic GDF/SMAD axis”), suggesting oncogenic vulnerabilities accrued upon double TS (p53 and ARF)
loss emerge as alternative therapeutic targets. However, it remains unknown how ARF inactivates PAF1C in a
gene-specific manner and whether the oncogenic GDF/SMAD axis has any diagnostic and therapeutic value.
This small grant proposal aims at addressing how ARF inactivates PAF1C in a gene-specific manner
to restrain tumor promoter programs and to evaluate the therapeutic value of targeting the oncogenic
GDF/SMAD program. Work in this proposal is guided by these previous findings and critical gaps in knowledge
to test the central hypothesis that ARF binds Paf1 and the gene-specific factor RUNX1 to block PAF1C
assembly in a gene-specific manner thereby restraining tumor promoter programs. To test the underlying
hypothesis, we will leverage biochemical and genetic approaches as well as clinically and molecularly annotated
preclinical models. Specifically, we will first investigate how ARF binds Paf1 and RUNX1 to block PAF1C
assembly in a gene-specific manner (Aim 1), and then probe if tumors bearing double TS (p53 and ARF) loss
exhibit reactivation of the oncogenic GDF/SMAD axis and examine its therapeutic and diagnostic potential (Aim
2). Together, elucidating the mechanisms by which ARF negatively regulates PAF1C-dependent tumor promoter
transcriptional programs will improve our understanding of an important biological process and offer alternative
opportunities to target TS loss in cancers with dual ARF and p53 inactivation (such as sarcoma, pancreas, and
lung adenocarcinoma), which is in-line with NCI’s mission to identify novel targets to move the discoveries from
the bench to the clinics.

Public health relevance
PROJECT NARRATIVE A large body of work has defined how the ARF tumor suppressor controls p53-dependent mechanisms to regulate cell growth, but p53-independent mechanisms of ARF tumor suppression are poorly understood. We found a previously overlooked mechanism of p53-independent ARF tumor suppression whereby ARF selectively targets the Polymerase Associated Factor 1 (PAF1C) to dampen pro-growth programs that are turned on upon p53 loss. Therefore, elucidating the mechanisms by which ARF blocks PAF1C and how loss of ARF elicits select oncogenic programs will provide new biology and an alternative opportunity to target cancer vulnerabilities upon dual inactivation of p53 and ARF.